Molecular mechanism of tetanus neurotoxin pathogenesis

Project Summary
Tetanus has been a major deadly infectious disease throughout human history. It is caused by
the spore-forming anaerobic bacterial pathogen Clostridium tetani, which can germinate within
the deep wound and produce a potent bacterial toxin known as tetanus neurotoxin (TeNT), which
is the sole cause of tetanus’s characteristic spastic paralysis symptoms. The mysterious
connection between deep puncture wounds and tetanus disease was already recognized by
ancient civilizations. Modern studies have now established the structure and function of TeNT: it
acts by first targeting motor nerve terminals and then mysteriously undergoes retrograde transport
into the spinal cord and then re-enters inhibitory neurons and blocks inhibitory neurons, leading
to hyperactivity of motoneurons and muscle spasms. However, how the toxin traffics into the
spinal cord has remained a major mystery for over a century. Here our preliminary studies have
identified potential host factors that may mediate trafficking of TeNT into the spinal cord and our
proposal seeks to carry out a comprehensive set of studies to examine TeNT binding to host
factors at the biochemical level, resolve the toxin-host factor complex structure using an X-ray
crystal structure approach, examine co-trafficking of TeNT and host factors within
compartmentalized neuronal cultures, and evaluate the role of host factors for TeNT in vivo
dynamics and pathogenesis using genetically modified mouse models. Our proposed studies will
establish the long-sought-after host factor that mediates trafficking and pathogenesis of TeNT in
animal models, thus solving a century-old major puzzle in our understanding of tetanus etiology.
Our studies may also reveal retrograde trafficking pathways important for neuronal health and for
delivery of therapeutics into the central nervous system.

Public health relevance
Project Narrative Tetanus, also known as “lockjaw”, has been a major deadly infectious disease throughout human history. It is caused by tetanus neurotoxin (TeNT) produced and released by the bacterial pathogen Clostridium tetani. TeNT causes the disease by blocking inhibitory neurons in the spinal cord, but how this toxin reaches the spinal cord remains a mystery. Here we aim to identify the host factor that transports TeNT into the spinal cord and establish the molecular mechanism underlying the pathogenesis of TeNT in vivo in mouse models.